AhR suppression of T-bet+ B cells in SLE

Project Summary: This proposal will answer two key questions. 1. Does IL-4 act through the aryl hydrocarbon
receptor (AhR) pathway to inhibit the development of double negative 2 (DN2) B cells? 2. How does IL-4 induce
endogenous ligands of AhR to suppress T-bet+ B cells? We recently showed that in SLE, down-regulation of IL-
4R and defective maintenance of resting naïve (rNAV) B cells were associated with increased development of
Tbet+CD11c+ activated naïve (aNAV) B cells and DN2 B cells. Co-culture of SLE B cells with IL-4 promoted the
maintenance of rNAV B cells and blocked both type I and type II interferon (IFN)-promoted development of aNAV
and DN2 B cells. Single-cell transcriptomics of lupus mouse B cell stimulated in vivo with IL-4 revealed up-
regulation of IL-4-induced1 (IL4i1). As an L-amino acid oxidase, IL4i1 can catalyze the synthesis of indole-pyruvic
acid (IPyA) derivative endogenous AhR ligands leading to upregulation of AhR response genes. Metabolome
analysis revealed that IL-4 induced AhR agonistic metabolites in B cells, including kynurenine (Kyn) and indole-
3 metabolites. In the absence of IL-4, AhR agonists 6-Formylindolo[3,2-b]carbazole (FICZ) and Kyn significantly
suppressed IFNβ and TLR7-induced T-bet+CD11c+ IgD− B-cell development. We hypothesize that IL-4 activates
AhR through a combined effect of IL4i1 and IDO1 to promote the formation of endogenous AhR ligands in B
cells. In Aim 1, we will determine if AhR is required to inhibit T-bet+ B cell development in mice and what
pathways and metabolites are involved. This will be tested using conditional AhR-deficient mice under chronic
TLR7 stimulation conditions (Aim 1a). The pathway for the production of AhR ligands, including indole-3
metabolites and Kyn, will be determined using Il4i1−/− mice and Ido1−/− mice (Aim 1b). The ability of AhR agonistic
metabolites to regulate T-bet+ B cell development in vivo will also be tested (Aim 1c). In Aim 2, we will use B
cells derived from SLE patients to determine if AhR is required for IL-4 to suppress DN2 B cell development
(Aim 2a). We will further determine if modulation of IL4I1, IDO1, and their downstream metabolites can alter the
development of DN2 B cells (Aim 2b). Significance. A primary focus in SLE research has been studies of
elevated pro-inflammatory factors that drive pathogenic autoimmune responses. We propose that therapies
designed to promote long-term homeostasis in otherwise abnormally stimulated immune cells could be more
efficacious and less toxic. Identifying small molecular metabolites that act directly in B cells to induce
homeostasis may lead to the development of orally active druggable targets that are efficacious in treating SLE.
Innovation. The proposed project is novel as B-cell endogenous metabolic ligands that can maintain B-cell
homeostasis and suppress T-bet+ B-cell development are unknown. Team and Environment. Drs. Mountz,
Rubio, and Hsu have a history of collaboration to study cytokine-mediated B cell single cell transcriptomics and
pathogenesis in SLE. Dr. Barnes, Director of the UAB Targeted Metabolomics and Proteomics Laboratory
(TMPL), will provide expertise in metabolomics analysis.

Public health relevance
PROJECT NARRATIVE In the proposed work, we have identified a distinct pathway that counteracts the development of autoantibodies in systemic lupus erythematosus (SLE). We will use state-of-the-art technologies to determine how surface and intracellular signals including biochemical metabolites can act together to maintain this pathway in B lymphocytes. Successful completion of the proposed work should help design better strategies to promote B- cell homeostasis for SLE patients.